The role of neutralizing antibodies in natural and treatment-induced control of hepatitis B with and without HIV-1 co-infection

Summary
This proposal aims to understand the effects of HIV on the humoral immune response to hepatitis B by
focusing on HBV-specific neutralizing antibodies (NAbs), B cell repertoires, and monoclonal antibodies that
develop after acute hepatitis B infection or after treatment-induced control of infection. This proposal will study
185 persons (74 HIV+) in the MACS-WIHS Combined Cohort Study who had acute hepatitis B while in follow-
up and whose outcome of either spontaneous control (n=163) or chronic infection (n=22) was previously
determined. We will also study an additional 21 participants with functional cure while on HBV treatment
(treatment-induced control). The first Aim focuses on plasma NAb responses during and 30 months after
spontaneous control of acute HBV infection in persons with and without HIV infection. We hypothesize that in
persons with HIV (PWH), the NAb responses will be weaker and less durable than in persons without HIV
infection. Decreased durability of NAb responses could contribute to the increased risk of HBV reactivation with
HIV infection. We will also assess plasma NAbs in participants with treatment-induced control of infection. We
hypothesize that these participants will demonstrate high NAb titers similar to those with spontaneous control
of acute infection. In the second Aim, we will isolate HBV surface antigen (HBsAg)-specific B cells from
specimens obtained during acute infection or before and after treatment-induced control. We will compare the
molecular features of HBsAg-specific B cell receptors between those with spontaneous control of acute
infection, those who develop chronic hepatitis B, and those with treatment-induced control of infection. We will
also determine the effects of HIV on these molecular features. In the third Aim, we will clone monoclonal
antibodies (mAbs) from these HBsAg-specific B cells and determine the mAbs’ functional characteristics. We
expect that the mAbs from persons with spontaneous control of acute infection will bind with higher affinity and
neutralize more potently than those who develop chronic infection, and that post-control mAbs from treatment-
induced controllers will be more potent than pre-control mAbs. We also expect that HIV will decrease the
affinity and potency of anti-HBs mAbs. Innovative aspects of this project include: 1) The unique cohort with a
large number of incident HBV infections with either spontaneous control or viral persistence in people living
with and without HIV infection, as well as rare individuals with treatment-induced control of HBV, 2) The ability
to detect NAb responses in plasma from human subjects, and 3) The ability to isolate HBsAg-specific B cells
for ex vivo study. To date, such studies have not been possible, explaining why there is little information on
NAb responses in HBV-infected humans. Results from this proposal will contribute to our understanding of the
effects of HIV on the immune response to hepatitis B and could facilitate development of a functional cure for
hepatitis B, the leading cause of cirrhosis and hepatocellular carcinoma worldwide.

Public health relevance
Narrative Of persons living with HIV, up to 90% have been infected with hepatitis B and up to 10% have chronic hepatitis B, but currently no cure is available. Using novel techniques and specimens, this proposal will provide data on the role of the humoral immune response including neutralizing antibodies in plasma, the B cell repertoire, and monoclonal antibodies in natural control of HBV and how these are affected by HIV. These data could lead to a functional cure for HBV in people with and without HIV.